ViTrack: Wearable, accurate, continuous blood pressure monitor to improve outcomes in hypertensive diseases of pregnancy

Abstract: We have developed ViTrack™, a cuffless, wrist-wearable device that uses a fundamentally new
method to accurately and non-invasively measure BP continuously. ViTrack’s beat-to-beat accurate
measurements, irrespective of patient movement or wrist level to the heart, provide the patient’s circadian BP
pattern, including 24-hr mean BP, nighttime BP, and BP variability (BPV). In addition, ViTrack also measures
heart rate and respiratory parameters and advanced hemodynamics. The hypertensive diseases of pregnancy
(HDP) are a significant cause of morbidity and mortality. The current standard for measuring BP in pregnant
women is the periodic use of oscillometric arm-cuff devices. The oscillometric devices indirectly estimate systolic
(SBP) and diastolic BPs (DBP) based on artery wall oscillations during cuff-deflation. Measurement errors
inherent to this indirect method, patient posture/movement, and wrong cuff size lead to unreliable BP
measurements in 50% of routine office visits. Oscillometric device errors are compounded in pregnant women
due to hemodynamic and vascular changes that reduce oscillations of the arterial wall, resulting in BP
underestimation. In contrast, these hemodynamic changes will have less impact on ViTrack measurements
because it utilizes pressure-dependent spatiotemporal skin displacement to measure SBP and DBP directly. In
addition, random clinic measurements during antenatal visits lead to a 30% wrong diagnosis of HDP due to white
coat or masked hypertension. In addition, there is a need for remote and continuous accurate measurement of
BP for prediction and early deduction of preeclampsia. The 24-hour BP parameters, such as 24-hr mean SBP,
nighttime BP, and BPV, are better predictors of preeclampsia than clinic BP measurements. ViTrack, the first
standalone, wearable, connected device, can provide remote, accurate circadian BP data for correct diagnosis
and enable predictive monitoring for better outcomes.
Our objectives in this Phase II study are: (1) to assess the accuracy of ViTrack SBP and DBP measurements in
pregnant women and as well as in women with severe preeclampsia; (2) to evaluate patient tolerance (i.e.,
comfort) and reliability of ViTrack’s beat-to-beat 24-hr BP measurements, and assess usability; (3) to compare
the 24-hr BP profile in pregnant women with and without HDP; and (4) to compare the number of
hypotensive/hypertensive episodes with ViTrack continuous measurements vs. the current standard of care of
intermittent cuff measurements. The data generated will validate ViTrack as the first standalone wearable
technology for accurate and continuous monitoring of BP during pregnancy.

Public health relevance
Project Narrative The hypertensive diseases of pregnancy are a significant cause of morbidity and mortality. ViTrack™ is a cuffless, wrist-wearable device that uses a fundamentally new method to accurately and non-invasively measure blood pressure. This study will validate ViTrack as the first standalone wearable device for accurate and continuous blood pressure monitoring during pregnancy.